MANAGEMENT INFORMATION SYSTEMS SUPPORT SERVICES

The purpose of this contract is to provide technical support services, primarily computer programming, system documentation, procedures development, and operational support to the Office of the Director (OD), National Cancer Institute (NCI), for the expansion, maintenance, and operation of NCI's Management Information Systems (MIS) and in support of other coordination and information processing activities of the Management Information Systems Branch (MISB).